Promoting Sustained Viral Suppression Through Implementation of an Adapted Evidence-Informed Low-Barrier Care Model in a System of HIV Primary Care Clinics

PROJECT SUMMARY/ABSTRACT
The goal to end the HIV epidemic (EHE) in the United States cannot be achieved if people with HIV (PWH)
do not achieve sustained viral suppression (VS). However, more than half of PWH in the US do not receive
regular HIV care, due largely to social and structural factors like stigma and discrimination, poverty, and care
complexity, as well as conditions like mental health and substance abuse. Additional approaches to care delivery,
especially for PWH experiencing compounding barriers, are needed to close the gap in sustained care and VS.
Low-barrier care (LBC) is a package of implementation and care engagement strategies developed
specifically to address barriers experienced by PWH with complex needs and has been shown to significantly
improve VS among this population. The original model of standalone LBC clinics, however, may have challenges
in scalability due to feasibility and limited reach to PWH within large areas. In contrast, adapting LBC strategies
for integration into existing HIV primary care sites has the potential to facilitate greater use of this promising
model of HIV care while also engaging more PWH with unaddressed needs. The overarching goal of this
proposal is to evaluate the implementation and effectiveness of adapted LBC strategies in a system of 12 HIV
population-centered health homes (PCHHs) funded by the Chicago Department of Public Health (CDPH) using
a pragmatic trial design. Guided by the EPIS framework, we will achieve this goal through three specific aims:
(1) Facilitate adoption, adaptation, and implementation of LBC strategies by PCHHs using a learning
collaborative. Learning collaboratives are widely used, evidence-based implementation strategies. Following
best practices, a lead facilitator and subject matter experts will help PCHHs explore and prepare protocols for
implementation of LBC strategies while trained practice coaches will provide technical assistance around
implementation at each site. CDPH has strong interest in integrating LBC strategies into PCHHs and will both
mandate PCHH participation in the learning collaborative and encourage LBC implementation through additional
funding. We will assess the process of adoption and implementation of LBC strategies using mixed methods.
(2) Evaluate site-specific and system-wide effectiveness of integrated LBC strategies at improving
sustained care and VS. Using a single-arm, pre–post trial design, we will assess if rates of retention in care
and VS improve in the two years following ramp-up of LBC strategies. We will also examine contextual factors
and implementation fidelity using mixed methods to explain variability in outcomes across PCHHs.
(3) Assess implementation cost and sustainment of LBC strategies among PCHHs. We will examine
implementation costs over time and plans for sustainment using mixed methods.
Our proposal directly responds to RFA-AI-21-024 and is consistent with the NIH Office of AIDS Research’s
high priority of implementation science to improve HIV service delivery and reduce disparities in treatment.
Results from this study will facilitate the use of LBC strategies in new settings to reach PWH with complex needs.

Public health relevance
PROJECT NARRATIVE Getting and keeping people with HIV (PWH) on HIV treatment and virally suppressed (i.e., can no longer transmit the virus) is critical to ending the HIV epidemic in the US, but many PWH still face numerous barriers accessing HIV care, especially if they experience complex needs like poverty or untreated mental health conditions. This study evaluates a set of low-barrier care strategies adapted for Ryan-White-funded HIV primary care clinics designed to make it easier for PWH with complex needs to get into care. Results from this study will facilitate the use of low-barrier care strategies in new settings to reach more PWH who are currently out of care.